Administrative Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The Administrative Core of the Center for Human Health and the Environment (CHHE) ensures
coordinated, efficient, and effective management of all components of the Center, provides
essential communication, resources and programs that encourage interdisciplinary
collaboration for the advancement of assistant and associate professors in environmental
health sciences (EHS), and fosters career development through one-on one mentoring,
grantsmanship assistance, and a Scored Grant program that fuels enhanced EHS research
grant submissions across the Center. The Administrative Core facilitates expansion and
translation of EHS research by its multi-disciplinary members, especially in NIEHS priority areas
relevant to the five CHHE Research Interest Groups (RIGs) which are: 1) Behavior and
Neuroscience, 2) Genes, Environment, and Precision Health, 3) Health and Airborne
Contaminants, 4) Environmental Health Disparities, and 5) Water and Emerging Challenges.
The RIGs provide members with an opportunity for leadership experience, and the co-leads are
varied in their tenure level, social and teaching perspectives, research disciplines, and university
affiliation. NC State (a land-grant university), East Carolina University (ECU, a medical
university), and North Carolina Central University (NCCU, an historically black university), are all
represented in CHHE leadership. The Administrative Core facilitates communication, funding,
and oversight for the other CHHE Cores (Systems Technology, Community Engagement, and
Translational Research Support) and programs, which are the roots from which CHHE
members grow. Cores provide clinical advice and resources, data analysis support, strong ties
to community stakeholders surrounding our affiliated campuses, and high-quality data to
Center members. The Administrative Core facilitates communication to and from its
membership to provide Center information and receive input on Center/Core services,
engagement opportunities, and activities. Through a highly effective, multi-directional CEC,
CHHE and the Administrative Core transmit new knowledge to communities and affected
populations and receive information from the CEC and the Stakeholder Advisory Board (SAB)
regarding community concerns and needs. In addition, the Administrative Core has developed a
robust career development program that complements the highly competitive Pilot Project
Program. Together, they provide foundational funding, mentorship, intellectual support,
collaborative interaction, leadership opportunities, and practical training essential for CHHE
members to become EHS leaders and compete effectively for extramural research grants, with
an emphasis on enhancing the success of assistant professor-level faculty. Through these
various efforts, the Admin Core provides the resources and infrastructure that enhances the
research impact and capacity of Center members beyond what they could have achieved on
their own and remains a vehicle for multi-directional communication within and between its
internal and external stakeholders.